Biostatistics, Epidemiology, and Research Design Core

DACCOTA-Biostatistics, Epidemiology, and Research Design Core
Summary: The Biostatistics, Epidemiology, and Research Design Core will provide support in the
areas of methodology, biostatistics, epidemiology, research design, and biomedical informatics. We
will create meaningful and enduring partnerships among the affiliated universities and research
institutes to centralize and integrate methodological and bio-statistical research support for all
participating clinicians and non-clinicians involved in cancer research. This core will promote
solution‐oriented studies and practice-based evidence to move evidence into action by bringing
together a diverse group of professionals with expertise in the areas of methodology, biostatistics,
epidemiology, and biomedical informatics related to cancer. This core will strengthen relationships
across the policy, practice, and research sectors by building a high‐performing and sustainable
enterprise with a reputation for relevance, excellence, and influence. Our goal is to develop
innovative biostatistics methods for translational science, including methods for solving diagnostic
problems and evaluating causal mechanisms (such as environmental and genetic) that relate to
cancer research. We also plan to develop new approaches to study recruitment that will improve
the cost-effectiveness and efficiency of CTR.

Public health relevance
DACCOTA-Biostatistics, Epidemiology, and Research Design Core Narrative: By linking biostatisticians and epidemiologists with established cancer researchers, the Biostatistics, Epidemiology, and Research Design Core (BERDC) will implement a novel collaborative program that can generate more timely and holistic cancer research that is translational in nature. The mission of the BERDC is to effectively leverage existing expertise and resources across regional academic and health care institutions to create a nationally recognized center of excellence supporting cancer research through innovation, intra-disciplinary collaboration, and public and private partnerships. Strong biostatistics leadership and participation in all aspects of biomedical research are considered essential to the mission of the Dakota Cancer Collaborative on Translational Activity (DACCOTA).